Functional Analysis of Programmed Genome Rearrangement

An individual's genome provides a complete set of instructions for achieving development, regulating
physiology and passing heritable information to the next generation. These instructions are encoded in the
linear sequence of DNA molecules (e.g. genes) and in the higher-order structures of chromosomes and
subchromosomal regions (e.g. regulatory elements). Alterations at any scale can severely impact an
individual's health, survival and ability to reproduce. It is therefore not surprising that life has evolved a variety
of genes and molecular pathways that contribute to maintaining the integrity of information encoded in the
genome, nor is it surprising that independent evolutionary lineages have evolved novel pathways or novel
modifications to their ancestral genome biology. Studying these diverse mechanisms can provide critical
comparative perspective on the cellular, molecular and evolutionary underpinnings of human genome biology
and have the potential to reveal new approaches to modulating related pathways in human.
Following this philosophy, my lab has sought to understand the functional and evolutionary mechanisms
that underlie the remarkable diversity of genome biologies that exist among deep vertebrate lineages. Our
recent work has focused on dissecting the causes and consequences of programmed genome rearrangement
(PGR) in the sea lamprey (Petromyzon marinus). In lampreys, PGR involves changes in the physical structure
(and content) of the genome that occur in a highly predictable and programmatic manner during early
development. These changes result in the reproducible loss of a specific subset of genes from all somatic cell
lineages. In total, approximately 20% of the lamprey's genome is eliminated from somatic cells and retained
only by germ cells. Recent progress in this line of research has shed light on the cellular/developmental
mechanisms of PGR and the functions of eliminated genes. Our analyses of PGR have demonstrated that
canonical silencing mechanisms (DNA and histone methylation) contribute to elimination of DNA during PGR,
particularly during later stages of elimination. These studies have also revealed that eliminated genes
contribute to the development/maintenance of germline when normally expressed and oncogenesis when
somatically misexpressed (in other vertebrates). This proposal seeks to continue our efforts in characterizing
the mechanisms and functional outcomes of PGR and extend these toward identifying genes and molecular
pathways that can impact the biology of the human genome, germ/stem cells and cancer. Proposed studies
aim to address several outstanding challenges with respect to PGR: 1) Precisely defining the sequence context
of PGR-associated epigenetic changes and their interactions with other molecules, 2) Identifying other
pathways that contribute to PGR, especially the earliest stages that involve the targeting of sequences for
elimination and the differential migration of eliminated chromatin during anaphase, and 3) Characterizing the
function of eliminated genes, particularly in the contexts of genome stability/instability and reprogramming.
! 1!

Public health relevance
Lamprey is a vertebrate that undergoes developmentally programmed genome rearrangements, which result in the reproducible elimination of ~20% of the genome from nearly all somatic cell lineages (this material is retained only in the germline). Our proposed studies will allow us to unravel the mechanisms by which lamprey physically reengineers its genome, and resolve the function of genes that are eliminated from somatic cell lineages. If funded, these studies will contribute to our fundamental understanding of cellular mechanisms that contribute to stability and change in vertebrate genome structure as well as gene regulatory changes that mediate the development of germ cells, epigenetic maintenance of pluripotency and oncogenesis. ! 1!